Aging and Dysfunction in the Peripheral Vestibular System

Project Summary
Vestibular dysfunction becomes more prevalent with age and it is estmated that more than 80% of people over
80 years old experience dysfunction5. Furthermore, approximately 8 million adults in the US suffer from
balance impairment due to damage to the peripheral vestibular system, but effective treatments for balance
dysfunction are virtually non-existent. Vestibular hair cells within vestibular canal and otolith organs convert
hair bundle motion into receptor potentials and sensory information is relayed to the brain by action potentials
in vestibular afferent nerves. Afferents in central zones of vestibular neuroepithelia exhibit different responses
to vestibular stimuli than afferents in peripheral zones. There are three types of vestibular afferents: calyx-only
afferents innervate one or more type I hair cells, bouton dendrites innervate type II hair cells and dimorphic
afferents contact both hair cell types. Calyx-only afferents are present only in central zones and have irregular
firing patterns, whereas dimorphic afferents exist in both zones and have regular firing patterns. We will study
age-related dysfunction in calyx-bearing afferents in gerbil vestibular organs using novel preparations
developed in the laboratories of the principal investigators. We will use electrophysiological, hair bundle
stimulation, immunohistochemical and behavioral approaches to address age-related changes in mature and
aged vestibular epithelia. In Aim 1 we will determine if functional changes in vestibular hair cell
mechanotransduction and/or basolateral currents occur with age. Aim 2 will test the hypotheses that synaptic
degeneration of calyx terminals will manifest as morphological uncoupling of type I hair cells from their
associated calyces and deficits in vestibular evoked responses and behaviors. In Aim 3 we will directly
investigate changes at the type I hair cell/calyx synapse by recording spontaneous activity and responses to
hair bundle stimulation in mature and aged calyx afferents. Our investigative team is uniquely positioned to
carry out the proposed studies. Results from this work will provide new information on how the aging process
impacts peripheral vestibular signals and may inform development of vestibular neurotherapeutics targeting
afferent nerves in order to restore normal vestibular function.

Public health relevance
Project Narrative Vestibular dysfunction becomes more prevalent with age and contributes significantly to falls in the elderly, but underlying causes are poorly understood. We will study synaptopathy in the vestibular periphery using a combination of electrophysiological, immunohistochemical and behaviorial approaches. Identifying impairments of the vestibular signaling pathway in aging has important implications for developing new therapies for patients with vestibular dysfunction.